Human Subject Protection and Disclosure Risk Analysis

HUMAN SUBJECT PROTECTION AND DISCLOSURE RISK ANALYSIS DESCRIPTION (provided by applicant): This research program aims to answer the call for knowledge and innovation that has arisen out of recent events and inquiries about studies involving human subjects. Analyses underway now at influential public institutions such as the National Academy of Sciences and the Institute of Medicine are likely to call for new research on the risks of human research. In the area of social science research, we expect those calls for research to emphasize the reduction of disclosure risk and the creation of new responsibilities at data archives. The Survey Research Center and the Inter-university Consortium for Political and Social Research at the University of Michigan propose four closely related projects related to the protection of human subjects through disclosure risk analysis and disclosure limitation. These projects specifically address the following topics: I. Informed Consent and Perceptions of Risk and Harm in Survey Participation II. Estimation of Disclosure Risk and Statistical Methods for Disclosure Limitation III. Statistical Disclosure Control: Best Practices and Tools for the Social Sciences IV. Resources for the Secure Dissemination of Human Subjects Data The results of this program of research will be new insights into disclosure risk and its elimination, and new procedures and best practices for accomplishing these goals, along with public programs and training to disseminate the knowledge.